Cardiac Response to Obstructive Sleep Apnea: Direct Effects and Preconditioning Protein in-vitro

Project Summary
Obstructive sleep apnea (OSA) is known to be correlated with cardiovascular diseases (CVD), yet
controlled clinical trials showed that CPAP treatment was insufficient to alleviate CVD risk in all patients. Current
tools fail to identify the mechanistic pathways involved in OSA-related CVD pathophysiology, and residual CVD
risk may persist despite CPAP treatment. Conversely, some studies have identified OSA as possibly protective
against myocardial infarction preconditioning consequences, highlighting significant knowledge gaps in
understanding the mechanisms linking OSA and CVD. This research project aims to elucidate the complex
relationship between OSA and CVD through an innovative "heart-on-a-chip" platform combined with validated
intermittent hypoxia (IH) protocols. Specifically, we will develop and validate physiologically relevant IH protocols
using endothelial cells, comparing responses against patient tissue samples. These validated protocols will then
be applied to our "heart-on-a-chip" model to investigate the direct impact of OSA-induced IH on cardiac structure
and function, providing insights into OSA-specific cardiovascular diseases. Additionally, we will examine whether
different patterns of OSA-associated IH can provide cardiovascular protection through preconditioning
mechanisms prior to ischemic insult and identify the underlying pathways. This comprehensive approach
addresses current limitations in OSA research by providing physiologically relevant in vitro models that can
directly test competing hypotheses about OSA's cardiac effects. Our research has the potential to identify novel
therapeutic targets and improve the clinical management of OSA patients at risk for cardiovascular
complications.

Public health relevance
Project Narrative Some patient populations, such as those with obstructive sleep apnea (OSA), are significantly more susceptible to cardiovascular diseases, yet the mechanisms linking these conditions remain poorly understood. Here we propose using tissue engineering tools coupled with patient studies to investigate outstanding questions about how OSA impacts cardiovascular health and prospects for patients.